REGIONAL CEREBRAL BLOOD FLOW CHANGES DURING ANTICIPATORY ANXIETY

Examines regional cerebral blood flow changes in normals, in generalized anxiety and in panic disorder patients while anticipating a painful electric shock and compare them with self reports and simultaneously occurring peripheral autonomic changes.